VASOACTIVE INTESTINAL PEPTIDE DIAGNOSIS OF LEUKEMIA

The object of this research is to better understand how peptide neurotransmitters modulate human lymphocyte function and in particular, how these neuropeptides affect proliferation and differentiation of lymphoblasts.